Genomics of Salmonella Typhi in Samoa: Population structure and genomic epidemiology

Project Summary / Abstract
Samoa is an island nation in the South Pacific (population ~200,000). For decades and despite improved water
quality and sanitation, Samoans have faced endemic typhoid fever, a potentially fatal human host-restricted
bacterial infection of the blood, hepatobiliary tree, and intestine caused by Salmonella enterica serovar Typhi
(S. Typhi). We recently described the epidemiology of endemic typhoid fever in Samoa by person, place, and
time (Sikorski et al., accepted, Clinical Infectious Diseases, 2020), but the mechanisms sustaining transmission
– either direct spread or indirect environmental amplification – remain unknown. Bacterial whole genome
sequencing (WGS) is a modern molecular tool that can establish phylogenetic relationships, test for antibiotic
resistance and virulence factors, as well as detect outbreaks. Paired with high resolution epidemiologic and
geospatial data (i.e., data generated by the Samoa Typhoid Fever Surveillance Initiative) WGS can help to
explain origins, evolution, clustering, and transmission patterns. Our long-term goals are to examine the
genomic population structure and evolution of S. Typhi circulating in Samoa using WGS and to combine
comparative genomics with geospatial epidemiology to help explain its endemicity. Large-scale genomic
studies describe the emergence and global spread of aggressive extensively-drug resistant S. Typhi strains,
but none have focused on Samoa. The genomics S. Typhi in Samoa not known nor is the date or geographical
source of introduction. Our preliminary WGS analyses of 176 S. Typhi isolates from Samoa from 1992-2018
show (i) an exclusive Samoan genotype that appears nowhere else in the world, (ii) geospatial clustering of
genomically related isolates, and (iii) the presence of unique genes found only in the Samoan isolates. We
hypothesize that a unique strain of S. Typhi entered Samoa decades ago and expanded into the dominant
circulating strain, and asymptomatic chronic gallbladder carriers of the strain serve as an effective long-term
reservoir and source of infection. We propose two Specific Aims: (1) characterize the genomics of S. Typhi
causing clinical disease in Samoa, and (2) define the role of asymptomatic S. Typhi carriers (N=24 to date)
using combined WGS and geospatial analyses. Isolates from Samoa will be sequenced and assembled and
then compared with the global collection of S. Typhi (~3,400 isolates) using single nucleotide polymorphism
and Bayesian evolutionary phylogenetic analyses. We will apply our lab's large-scale blast score ratio pipeline
to identify any new and/or deleted genes. After funded training from the Institute for Disease Modeling we will
combine the data on genomic relatedness among S. Typhi isolates with clinical, epidemiologic, and geospatial
data to demonstrate local patterns of transmission. These detailed analyses have never been completed on
Samoan S. Typhi, and the results will be integrated into public health decisions and policies.

Public health relevance
Project Narrative To explain the enigmatic endemicity of typhoid fever in the small Pacific island nation of Samoa since at least the 1960s, despite steady improvements in water and sanitation, we hypothesize that a unique strain of S. Typhi entered Samoa decades ago and expanded into the dominant circulating strain, and asymptomatic chronic gallbladder carriers of the strain serve as an effective long-term reservoir and source of infection. Through our close collaboration with the Samoa Ministry of Health, the “Samoa Typhoid Fever Surveillance Initiative,” we propose a series of comparative genomic and geospatial analyses integrating whole genome sequence data of Salmonella Typhi isolates from Samoa with clinical and household epidemiologic data to determine the population structure, evolutionary origins, and local patterns of transmission including the relative role of asymptomatic chronic carriers of Salmonella Typhi. Where previous large scale phylogenetic studies of Salmonella Typhi have demonstrated the feasibility and public health utility of our experimental approaches, none have focused on Samoa nor been implemented as part of an accelerated and coordinated national typhoid control program; therefore, our results will not only contribute a Polynesian perspective to the field of Salmonella Typhi genomics, but also present new information on endemic typhoid fever to assist the Samoa Ministry of Health and our international collaborators in public health decisions.